Four-dimensional Adhesion Frequency Assay for Full Profiling of Receptor-ligand Interactions on Cells

PROJECT SUMMARY
This R01 application is responsive to the NIH initiative PAR-19-253 “Focused Technology Research and Development”.
Assays for measuring receptor-ligand affinity are valuable in many areas of biomedical research. The “gold standard”
surface plasmon resonance assay is limited to recombinant soluble receptors fixed on solid surfaces. The emerging adhesion
frequency assay (AFA) techniques can measure the receptor-ligand affinity on their native cellular membranes. However,
existing AFA methods can neither resolve the non-uniform distribution of receptors on single cells nor measure the rolling
cell adhesion under shear forces. In addition, currentAFAapproaches are generally bulky and low throughput, which require
tedious operation. Recently, we have invented a light-driven microrobot (LDM) platform as a non-invasive, programmable,
and multimodal cell-manipulation technology. Based on this versatile LDM platform, we propose to develop a paradigm-
shift four-dimensional (4D) AFA (i.e., integrated 3D translational AFA and 3D rotational AFA) to overcome these key
obstacles in the existing assays. In this R01 project, we will develop and validate our 4D AFA with the following features:
(1) measuring receptors on their native cell membrane environments, (2) resolving the non-uniformly distributed receptors
on single cells, (3) enabling both translational and rotational AFAs on an integrated platform, (4) investigating cell adhesion
under both shear force and tensile force, and (5) allowing on-chip multiplexed cell adhesion measurements. With such
features, the proposed 4D AFA has the potential to exceed current lab standards, address unmet needs in the field, and
enable high-throughput full profiling of receptor-ligand interactions at sub-cellular resolution. We will validate and improve
the 4D AFA performance using well-studied receptor-ligand pairs with variable affinities. We will further package and
apply the validated assay to investigate the binding of SARS-CoV-2 virus to angiotensin-converting enzyme 2 receptor and
to screen T cells for immunotherapy for cytomegalovirus infection. In this regard, we aim to demonstrate the far-reaching
potential of 4D AFA to enable improved research in areas ranging from clinical immunotherapy to fundamental biology.

Public health relevance
Project Narrative Measuring receptor-ligand interactions on cells is essential in a wide range of biomedical research and clinical applications. However, existing adhesion assays suffer frommany limitations, including bulkiness, low throughput, difficulty in resolving the non-uniform distribution of receptors on single cells, and the inability to measure both tensile and shear forces in cell adhesion. The goal of this proposed project is to develop a novel light-based four-dimensional adhesion frequency assay to overcome these key obstacles and enable a multiplexed and programmable three-dimensional profiling of both shear and tensile affinities of cells and viruses at sub-cellular resolution.